Outpatient Prescription Errors

[unreadable] DESCRIPTION (provided by the applicant): Medication errors cause substantial morbidity and mortality in the United States. However, relatively little is known about medication errors in the outpatient setting. The broad goal of this proposal is to improve outpatient safety. Specifically, this research plan promotes the understanding of the causes of outpatient prescription errors. The specific aims of this project are: 1) to develop and evaluate a novel reporting system in physicians' offices for detecting prescription errors; 2) to develop and evaluate a novel improvement system in community pharmacies to increase prescription error reporting by pharmacists; and 3) to analyze reports of outpatient prescription errors and understand their root causes. [unreadable] [unreadable] To achieve these specific aims, statewide research will be conducted utilizing qualitative and quantitative methods including root cause analysis, failure mode and effects analysis, and surveys. This research plan will promote patient safety by furthering the understanding of the causes of outpatient prescription errors in all outpatient populations, including rural, women, children, elderly, low income, and the chronically ill. [unreadable] [unreadable] The candidate is a clinical pharmacist with a strong desire to become a successful independent investigator in the field of patient safety. Specifically, the candidate would like to pose feasible, interesting, novel, ethical, and relevant research questions related to understanding outpatient medication errors. She would like to design and execute solid study designs, conduct the analyses, and communicate the results at both local and national levels. To develop these skills, she proposes an extensive curriculum in the responsible conduct of research, patient safety, statistics, root cause analysis, database management, communication, and epidemiology. The candidate's research environment is equipped to successfully support the proposal. Additionally, she will work closely with experienced investigators in the fields of Outcomes Research, Technology Assessment, and Human Factors Research. [unreadable] [unreadable] [unreadable]